TOWARD A RATIONAL USE OF PLASMA HVA IN MENTAL ILLNESS

Central dopaminergic transmission appears to be involved in the expression of some schizophrenic symptoms. The development of a technique to measure homovanillic acid in plasma (pHVA) has offered the possibility of performing serial measurements of this major dopamine metabolite.